Effects of Sensorineural Hearing Loss on Robust Speech Coding

Project Summary
Despite recent technological advances, people still suffer from communication difficulties that impact their
professional, social, and family lives, as well as their mental health. People with sensorineural hearing loss
(SNHL) struggle with understanding speech, particularly in noisy situations. In fact, people with similar degrees
of clinically defined hearing loss can have a wide range of speech-recognition abilities, likely due to differences
in underlying suprathreshold deficits that are hidden from current audiological assessment. Although a listener’s
sensitivity to simultaneously spectrally and temporally modulated (STM) sounds is known to be predictive of
speech-in-noise performance in individual listeners, the underlying mechanisms of this predictive power remain
a topic of active debate. Physiological evidence from our lab and others demonstrate that several forms of SNHL
(e.g., OHC and/or IHC dysfunction) affect within and across-channel modulation coding of signals in different
ways. For example, distorted tonotopy due to OHC dysfunction can affect the perceptually relevant within-
channel signal-to-noise ratio in the modulation domain, as well as across-channel temporal coherence of
modulations that are useful for source segregation. Despite these clear and varied implications for modulation
coding of signals, these effects are surprisingly understudied with respect to signal-in-noise coding, which is the
focus of the proposed work. We use a cross-species experimental design to collect anatomical, single-unit
AN-fiber, evoked-response, and diagnostic data from several pre-clinical chinchilla models of SNHL, as well as
evoked-response, diagnostic, psychophysical, and speech-in-noise data from human listeners spanning a range
of age and hearing status. Aim 1 is to characterize SNHL effects on within-channel modulation masking,
where the data collected will test the hypothesis that OHC and IHC dysfunction each degrade the perceptually
relevant neural modulation signal-to-noise ratio, but in distinct ways. Aim 2 is to characterize SNHL effects on
across-channel temporal coherence cues, where the data collected will test the hypothesis that distorted
tonotopy is prevalent in both animals and human listeners and has a perceptually relevant effect on peripheral
across-channel temporal coherence. Aim 3 is to characterize SNHL effects on STM sensitivity, where our cross-
species data will test the hypothesis that the predictive power of STM stimuli for speech-in-noise perception
arises largely from distorted tonotopy and the effects of SNHL on temporal modulation coding, rather than from
broadened tonotopic tuning or degraded temporal precision. Data will be harmonized in an open-source data-
science framework to facilitate future causal modeling by us and others. Our unique ability to quantitatively
synergize cross-species data within a rigorous perceptually relevant framework will allow us to test our general
hypothesis that SNHL has several distinct peripheral effects on modulation cues for signals in noise, which
contribute to individual differences in speech perception in noise. Long-term, this work will help to personalize
audiology by providing knowledge to stratify the clinical SNHL category in a framework of real-world significance.

Public health relevance
Project Narrative People with sensorineural hearing loss face the most difficulty understanding speech in noisy backgrounds, with significant individual differences in this ability across people with the same degree of clinically defined hearing loss. This study synergizes expertise in animal and human auditory neuroscience in a coordinated cross-species experimental design that will characterize the effects of sensory, neural, and synaptic dysfunction on modulation coding and perception of signals in noise. Data will be harmonized in an open-source data-science framework to facilitate short-term advances in our understanding of the relations between individual differences in peripheral pathophysiology and real-world listening, and long-term advances in personalized audiology to target treatment and counseling to individual patients, which will ultimately lead to better hearing health, quality of life, and lower healthcare costs.